RISE at UVI: Building Studentsâ Identities as Scientists

The University of the Virgin Islands, an undergraduate HBCU serving a unique population, proposes a
continuously improving RISE program for students in all the relevant biomedical and behavioral disciplines
across both the St. Thomas and St. Croix campuses. The program is designed to increase the diversity of
biomedical researchers, which is essential to developing the creative research teams needed to make future
ground breaking discoveries. The RISE Program will accomplish this with a sustained program designed to
build students’ identities as scientists. New features in the program were developed as a result of evaluation.
The specific aims are: Goal 1. The UVI RISE program will engage RISE students, build their intellectual
capacity, and provide continuous support such that 100% of the RISE students graduate; 95% apply to pipeline
programs in their senior year; 60% enroll in doctoral programs within 3 years of graduation. The baseline is
46% of graduates in the last funding cycle have matriculated into PhD programs. Goal 2. The UVI RISE
program will have a magnifying effect producing institutional change that impacts all students in relevant
departments such that the percentage of students enrolling in doctoral programs increases in all. Our goal for
biology and chemistry is that the percentage of alumni going on to PhD programs will increase from 20% to
22%; for mathematics and applied mathematics an increase from 14% to 16%; for computer science an
increase from 10% to 12%. The measurable objectives are that the RISE program will: (1) provide students
with a rigorous RISE curriculum including new skills development courses, (2) provide research education
opportunities both through extramural summer experiences and academic year research classrooms, (3)
develop strong, innovative partnerships with labs at research-intensive institutions, (4) provide students with
support and mentoring such that they see a clearly articulated career pathway for admission to selective
research universities and a structure for success, (5) provide the mentoring and inspiration to excel such that
at least one RISE student each year will apply to and be competitive for the MARC program, (6) increase the
number of UVI students accepted into competitive mainland summer research programs, (7) increase grades
of STEM majors through an innovative utility value intervention. The objectives will be accomplished with a
program that builds on past success and includes new courses, extramural research, presentations at
conferences, visiting scientists, workshops, journal clubs, and a network of support for students including
Individual Development Plans. The RISE program will be carefully evaluated following a comprehensive
evaluation plan and be improved based on the results of evaluation. The program will substantially increase
UVI’s ability to prepare students for careers in biomedical research.

Public health relevance
This project is relevant to public health because it will produce a cohort of rigorous trained, motivated undergraduates who are prepared to successful in highly competitive PhD programs and thus ultimately a group well trained biomedical researchers who will contribute to the quality and diversity of the scientific workforce. Diversity of the scientific workforce is key to the creativity of scientific research and the NIH mission. These University of the Virgin Islands students will contribute unique research perspectives because of their cultural, educational, and socioeconomic backgrounds; these perspectives will be important not only to addressing health disparities but also to breakthroughs across the scope of biomedical and behavioral sciences.